Dissecting Oxytocin Neural Circuits Involved in Prosocial Behavior

Project Summary
Social affiliation is critical to the physical and emotional health of a wide variety of species. Disruptions in social
functioning - a key feature of conditions like autism, social anxiety, and schizophrenia - can severely limit one's
capacity to cultivate healthy social relationships and bonds. The neural circuit mechanisms governing affiliative
social behaviors are not well understood, which is an important part of the social processes domain of the
Research Domain Criteria (RDoC) and relevant to several psychiatric disorders. Allogrooming (grooming
behavior directed toward another individual) is a major form of affiliative social contact through which animals
may form, maintain, and strengthen social relationships and is conserved in a wide range of social species,
such as birds, bats, rodents, canids, cats, equids, and primates. This project aims to understand the neural
mechanisms regulating allogrooming in mice by examining the oxytocin receptor (OXTR) system, a critical
modulator within the brain's `social behavior network'. The sponsor has previously identified a pathway from
the medial amygdala (MeA) to the medial preoptic area (MPOA) as essential for allogrooming in mice.
However, the specific neural encoding of oxytocin-responsive neurons in this circuit remains unknown. I will
gain exceptional training in powerful genetic approaches that allow us to target oxytocin receptor cells
specifically. The outlined proposal will 1) utilize in vivo optogenetics to manipulate oxytocin-sensitive MeA
neurons and their projections to the MPOA and BNST, 2) assess the role of OXTR specifically in the MeA on
prosocial behavior, and 3) utilize in vivo freely moving calcium imaging to optically record MeA OXTR neurons
during allogrooming behavior. The proposed study will provide an excellent training experience for the
applicant, and it will reveal how discrete, anatomically defined pathways descending from the MeA are
engaged during allogrooming. These results will set the foundation for a more incisive analysis of how OXTR
circuits shape social function in both health and disease.

Public health relevance
Project Narrative This project explores oxytocin's role in allogrooming using cutting-edge tools that record and manipulate oxytocin-sensitive neurons and neural projections from the medial amygdala to the medial preoptic area and bed nucleus of the stria terminalis. Enhancing understanding of social affiliation (e.g., allogrooming) representation in the brain may enable more effective therapeutic strategies for mental health.